Poly-Matching Causal Inference for Assessing Multiple Acute Medical Managements of Pediatric Traumatic Brain Injuries

Abstract
Clinical effectiveness research (CER) plays a central role in research related to emergency medical services for
children (EMSC). It is the conscientious use of the best available evidence in evaluating interventions, broadly
defined as medical treatments, health policies, or practice patterns, which could lead to improvements in health
care quality and patient outcomes. Observational data are more often used in the evaluation of healthcare
systems or complex clinical practice than randomized controlled trials (RCTs), due to practical or ethical reasons.
However, causal inference with observational data faces challenges: (1) Important covariates may be distributed
differently between treatment options; (2) Conventional statistical analysis lacks control for unmeasured
confounding. When the intervention is dichotomous, propensity score based adjustment is widely used to reduce
the confounding bias introduced by observed covariates, through matching, stratification or weighting. Matching
is a popular choice among researchers, as it creates data structures similar to RCTs, is easy to interpret, and
robust to misspecifications in outcome modeling. But there is a critical methodological gap hindering the use of
matching design when there are multiple (more than two) treatment options. This is due to the lack of good
matching algorithms to generate well matched sets and the increased complexity of post-matching inference.
Our overarching goal is to develop a statistically valid matching design (referred to as PMD) and subsequent
causal inference procedures for use with complex observational healthcare databases, where there are multiple
treatment arms or treatments over multiple time points. Specific aims: (1) Devise an innovative PMD for studies
with multiple treatment arms or treatments over time; Develop causal inference strategies for PMD based on the
potential outcome framework and sensitivity analysis strategies for assessing the unmeasured confounding
effect; (2) Evaluate causal mortality impact of severe TBI (sTBI) patients who received trauma care at different
type of trauma centers (PL1-level 1 pediatric, AL1-level 1 adult, and ML1-level 1 mixed trauma centers; PL2-
level 2 pediatric, AL2-level 2 adult, and ML2-level 2 mixed trauma centers); (3) Assess the effectiveness of 4
Tier 1-2 medical management/therapies (ICP monitoring, head CT scan, cerebrospinal fluid drainage,
decompressive craniectomy) on sTBI patient mortality; (4): Evaluate compliance with a Centers for Disease
Control and Prevention (CDC) head CT guideline for mild TBI (mTBI) patients by different types of hospitals.
This study is expected to fill a critical gap in EMSC research by extending the commonly used dichotomous
matching design to complex observational studies with multiple treatment groups. This project is significant and
our proposed methods are innovative as they include both observed confounding adjustment and unmeasured
confounding assessment. We envision that this general-purpose methodology will be widely applicable and can
benefit government agencies, policy makers, and social and health science researchers, where observational
data are often utilized for comparative outcomes research and program/policy evaluation.

Public health relevance
PROJECT NARRATIVE This research is relevant to public health because traumatic brain injury is the leading cause of morbidity and mortality in children and adolescents. The proposed study will develop an innovative poly-matching design (PMD) for comparative clinical effectiveness research (CER) and apply causal inference strategies to assess four acute medical management/therapies for pediatric traumatic brain injuries (TBI). The ultimate goal is to provide inno- vative methods for research related to emergency medical services for children (EMSC) and build the evidence base for clinical practice.